Role of FGF21 in DMD

PROJECT SUMMARY
Duchenne Muscular Dystrophy (DMD) is the most common muscular dystrophy seen in children, which affects
both muscle and bone. To date, the mechanisms that contribute to the poor skeletal health in DMD are not fully
understood and no targeted therapies exist to slow or halt the progression of osteoporosis and related fractures.
We have identified a novel bone-regulating myokine, FGF-21, which is typically not expressed in skeletal muscle
under physiological conditions, is dramatically increased in dystrophic skeletal muscles in DMD mouse models.
However, the mechanisms which drive FGF21 expression in dystrophic muscle and the pathological role of
FGF21 on bone metabolism in DMD are not clear, representing a significant gap in knowledge. The purpose of
this proposal is to identify the cellular source of elevated FGF21, determine the molecular mechanism(s) that
drive FGF21 expression, and to characterize the pathological effects of muscle-derived FGF21 on bone in DMD.
The cellular and molecular mechanisms of upregulated FGF21 expression will be determined in skeletal muscle
of dystrophic mouse models. The pathological role of muscle-derived FGF21 on skeletal muscle, bone and
whole-body metabolism will be determined by skeletal muscle conditional FGF21 knock out animals and in in
vitro cell models. Completion of these studies will not only provide understanding of the pathogenesis of DMD
skeletal abnormalities but also elucidate a novel muscle/bone crosstalk signaling pathway mediated via myokine
FGF21. The proposed studies will provide the groundwork for developing potential therapies targeting FGF21
signaling to manage poor bone health in DMD patients.

Public health relevance
PROJECT NARRATIVE The proposed research project aims to investigate the role of FGF21, a novel myokine, in Duchenne Muscular Dystrophy (DMD). The objectives of the study include understanding the mechanisms that lead to FGF21 expression in dystrophic muscle and examining how FGF21 contributes to the pathology of DMD, particularly in relation to muscle, bone, and whole-body metabolism. The project seeks to establish a foundation for comprehending the interactions between muscles and bones in the context of DMD, thus this work has the potential to shed light on the intricate mechanisms involved in DMD pathogenesis and may offer insights into novel therapeutic strategies.